Novel Coregulators of Estrogen Receptor in Enhancer-regulated Transcription

SUMMARY/ABSTRACT
Novel Coregulators of Estrogen Receptor in Enhancer-regulated Transcription
Estrogen (E2 or 17β-estradiol) and its nuclear receptor ERα play a critical role in the normal development
and disease conditions of multiple organs, including the mammary glands, by binding mostly to distal
enhancers. Increasing evidence suggests that functional dysregulation of ERα-bound enhancers can
profoundly alter normal transcriptional programs, resulting in developmental defects, diseases, and hormone
resistance. However, the molecular mechanisms underlying enhancer function/dysfunction are largely
unknown. One of the main objectives of the parent grant, R01GM137009, is to understand how the cooperative
interactions between YAP/TEAD and ERα control the context-specific function of ERα-bound enhancers in vivo
through enhancer reprogramming. Specifically relevant to this supplement application, we aim to determine the
functional attributes of YAP/TEAD in enhancer reprogramming during mammary gland development. To
achieve this goal, we plan to dissect mammary glands from mouse models (YAP knockout and overexpression
models) and isolate single cells for cell sorting or cellular phenotype analysis through flow cytometry. We are
requesting equipment funding to purchase a single-cell dissociator combined with a user-friendly flow
cytometer that will allow us to perform phenotype analysis of the mammary glands. This equipment is critical
for my lab to complete this parental R01 project.

Public health relevance
NARRATIVE Estrogen-regulated transcriptional programs are crucial for the normal development and disease conditions of multiple organs, including the mammary glands. These programs are tightly regulated by the binding of the estrogen receptor with enhancers. We hypothesize that the cooperative interactions between YAP/TEAD and ERα control the context-specific function of ERα-bound enhancers in vivo through enhancer reprogramming. To investigate this hypothesis, we require support from this supplemental equipment grant to purchase a single-cell dissociator combined with a user-friendly flow cytometer that will enable us to perform phenotype analysis of the mammary glands.